INRSA Training Grant in Gastroenterology

DESCRIPTION (provided by applicant): Training creative and productive academicians is a critical mission of gastroenterology programs. Emerging discoveries in related fields ranging from human genetics to molecular and cellular biology, microbiology and epidemiology have had major impacts on the understanding of pathophysiology of gastrointestinal diseases. The UCSF Division of Gastroenterology has been a leader in gastrointestinal research for over 40 years. In addition, allied Divisions and Departments at UCSF augment the training program by providing complementary and synergistic training experiences. During the past funding cycle, we have renewed our selection and training procedures to optimize the success of our trainees. The enhanced pool of applicants and trainees in our program attests to the success of our efforts. In this application, we propose to continue our training of innovative and creative academic investigators in gastroenterology.

Public health relevance
This application is for support of four training positions in an established program in digestive diseases that has been funded since 1975 at the Division of Gastroenterology, University of California, San Francisco. The Program's goal is preparing trainees for careers in academic luminal gastroenterology, and its track record in this regard is outstanding, with numerous graduates of the program now in leadership positions. The training environment is broadly interdisciplinary, reflecting the synergistic relationships of the Division of Gastroenterology with the IBD Center, the Immunology Program, the Cancer Center, the Institute of Molecular Medicine, and the graduate programs for Biomedical Sciences and Biological Sciences. These broadly interdisciplinary setting provides an ideal training environment for academic gastroenterologists of the future.